Reducing maternal prenatal depression to improve child cardiovascular health

PROJECT SUMMARY/ABSTRACT
It is critical to understand risk and protective factors for health to optimize developmental outcomes and inform
prevention of poor health behaviors across the lifespan. Research using longitudinal designs, multiple levels of
analysis, and experimental clinical trials are needed. Cardiovascular disease (CVD) is the leading cause of
death worldwide. The origins of adult CVD begin prenatally: High prenatal maternal depressive symptoms
robustly predict offspring CVD risk. However, knowledge on risk and protective factors for CVD for offspring of
mothers with high depressive symptoms has been correlational. There is a lack of experimental work using a
randomized controlled trial (RCT) design to understand potential mechanisms that contribute to children's CVD
risk following exposure to high maternal prenatal depressive symptoms across multiple levels (e.g., maternal
and child behaviors, physiology) over time. Although efficacious interventions to diminish depressive symptoms
among pregnant women exist, research has not investigated whether reducing prenatal maternal depressive
symptoms can reduce offspring cardiovascular risk. The current study proposes to leverage a RCT of an
effective psychosocial intervention for prenatal maternal depression to test whether reducing prenatal maternal
depressive symptoms improves offspring cardiovascular health at ages 3-4 years. We hypothesize that the
prenatal intervention operates by reducing both prenatal and postnatal depressive symptoms to improve child
outcomes. This study will identify intervention targets for offspring of mothers with high prenatal depressive
symptoms to reduce cardiovascular risk. These goals will be accomplished by building on a RCT
(R01MH109662) of an established psychosocial intervention that effectively reduces maternal prenatal
depressive symptoms. We propose to leverage this unique opportunity to follow up mothers and children who
participated in this RCT to test whether this intervention improves offspring cardiovascular health. This project
increases rigor of the existing correlational research by using an experimental RCT design. The following 3
aims will be addressed. Aim 1: To test whether reducing prenatal maternal depressive symptoms improves the
quality of food the mother feeds her child, maternal feeding behaviors, and modeling of eating behaviors at 3
years. Aim 2: To test whether reducing prenatal maternal depressive symptoms improves child diet, eating
behaviors, sleep, and physical activity at 3 years. Aim 3: To test whether reducing prenatal maternal
depressive symptoms reduces child CVD risk at 3 and 4 years, including BMI, waist circumference, body fat,
blood pressure, and arterial stiffness. This project will provide the strongest evidence to date for a mechanistic
model of prenatal maternal depressive symptoms' influence on child cardiovascular health. Importantly, the
project will also provide evidence for whether effective psychosocial interventions to reduce prenatal maternal
depressive symptoms should be used to reduce the burden of CVD in the next generation.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) is the leading cause of death worldwide, risk begins early in life, and as a result, policy organizations are recommending that optimal promotion of cardiovascular health begin during childhood. Prenatal maternal depressive symptoms predict offspring cardiovascular risk, though this association has not been demonstrated experimentally; as such, the proposed research will follow up a sample of offspring from pregnant mothers who participated in a randomized controlled trial to test whether reducing prenatal maternal depressive symptoms improves offspring cardiovascular health in early childhood. This research will determine whether an established, effective psychosocial intervention to reduce depression during pregnancy also reduces cardiovascular risk early in life in the next generation.